Controlling Catheter-Associated Urinary Tract Infections Using Smart Catheters with Rationally Designed Active Topographies

Catheter associated urinary tract infection (CAUTI) is one of the most common healthcare-associated
infections (HAIs), with a prevalence of 13 – 15% in the United States. CAUTIs are also blamed for
increased morbidity and mortality of affected patients with an estimated 13,000 deaths annually. It is
well known that the abiotic catheter materials are prone to colonization of microbes, which then ascend
the catheter via motility and biofilm formation, causing infections in the urinary tract. Due to the protection
of the biofilm matrix and slow growth of attached cells, biofilm cells are up to 1,000 times more resistant
to antimicrobials than the planktonic cells of the same species. Thus, CAUTIs are difficult to treat and
blockage of the catheter lumen can occur especially during long-term use, leading to stone formation
and infections of the bladder and even kidney. Treatment of CAUTIs with high doses of antimicrobial
agents can also adversely promote the development of multidrug resistant bacteria. Despite extensive
research to date, no current technology can provide long-term (>30 days) fouling control. This unmet
challenge motivated us to engineer smart catheters to ultimately eradicate CAUTI.
Recently, the PI’s lab developed a new antifouling strategy based on active topography that drives
magnetically responsive micron-size pillars to beat with a tunable frequency and force level. This was
achieved by loading Fe3O4 nanoparticles on the tip of each pillar and generating an electromagnetic
field using an insulated copper coil embedded in the catheter wall (thus does not change the catheter
profile). This novel design demonstrated unprecedented strong antifouling activities that can inhibit
biofilm formation of multiple species by up to 3.6 logs (99.98%) for 48 hours and remove mature biofilms
by up to 3.5 logs (99.97%) on demand with a stronger force, compared to the flat control. A prototype
catheter with micron-size pillars on the inner wall was engineered and remained clean for more than 30
days under the flow of artificial urine and the challenge of uropathogenic Escherichia coli (UPEC), while
both flat and static controls were completely blocked by UPEC biofilms within 5 days. These results
motivated the team to further develop this technology to also control biofouling of the outer catheter wall,
which is covered by urethral mucosa and involved in two thirds of CAUTIs. Integrated simulation and
experimental studies will be conducted to understand the mechanism of biofouling control by active
topography and the design principles for antifouling topographies on both sides of the catheter wall. The
best design will be further tested in vivo using a rabbit model of CAUTI induced by UPEC. Both CAUTI
prevention (up to 30 days) and removal of established biofilms will be evaluated.

Public health relevance
Project Narrative Bacterial biofilms play important roles in nosocomial infections including catheter associated urinary tract infections. This project aims to engineer novel non-fouling catheters which can provide long-term (30 days or longer) prevention of microbial adhesion and on-demand removal of established biofilms on both sides of the catheter wall. The results will have direct impacts on patient care and recovery. Thus, it has significance in infection control, which is critical to public health.